Statistical Methods for Information Synthesizing Using Multiple Existing Longitudinal Cohort Studies

PROJECT SUMMARY
Building on the valuable groundwork laid by the Collaborative Cohort of Cohorts for COVID-19 Research (C4R),
this research project aims to advance the statistical methods used in pooled cohort studies. Pooled cohort
studies are a powerful tool in clinical and epidemiological research, enabling the detection of subtle effects and
interactions and improving the generalizability of findings through increased sample diversity. However, they pose
unique challenges, particularly systematic missing data and potential heterogeneity across studies. Our goal is
to address these challenges and improve the robustness of pooled cohort studies. To achieve this goal, we
have structured four specific aims: Under Aim 1, we propose a novel Generalized Method of Moments (GMM)
framework for robust statistical inference across multiple studies dealing with systematically missing data. Our
investigation will probe into the missing data mechanism across multiple samples, employing density ratio weight-
ing to handle the heterogeneity in covariate and outcome distributions. Under Aim 2, we propose nonparametric
predictive models that leverage data from multiple studies with systematically missing data. We will develop a
gradient boosting algorithm for versatile prediction model accommodating predictors of varying detail. Addition-
ally, we will design algorithms for cohort-specific prediction models that take advantage of information from other
cohorts. Aim 3 extends the proposed methods for systematically missing data and cohort heterogeneity to right-
censored time-to-event data. Under Aim 4, we perform comprehensive evaluations through simulations and real
data analyses, and develop user-friendly analytical pipelines for the proposed methods. Our research design and
methods are centered around developing, testing, and refining these new statistical methods. These methods will
then be evaluated both via simulation and real-world application to the C4R data. The long-term objective is to
establish reliable tools for integrating multiple cohorts and conducting individual participant data meta-analysis.
The development of these robust statistical methods and a systematic pipeline for the pooled analysis of system-
atically missing data will provide valuable tools for researchers working with pooled cohort data. This project will
enhance the validity and reliability of findings from the C4R study, and thereby contribute to a more accurate un-
derstanding of risk and resilience factors for COVID-19 severity and outcomes. Our findings will be disseminated
widely, including the development of user-friendly software to facilitate the application of our proposed methods.

Public health relevance
PROJECT NARRATIVE This project aims to develop innovative statistical methods that improve the robustness and efficiency of combin- ing data from diverse cohort studies. Our research will focus on addressing key statistical challenges encountered in the Collaborative Cohort of Cohorts for COVID-19 Research (C4R), particularly those related to data harmo- nization, missing data, and study heterogeneity.